A statewide examination of the address-level relationships between residential eviction proceedings and overdose events in Rhode Island

PROPOSAL SUMMARY
In the wake of the COVID-19 pandemic, overdose mortality and affordable housing shortages have reached
unprecedented levels in Rhode Island and across the United States. Housing insecurity is a known risk factor
for overdose, yet the effects of residential eviction—a structural and policy-sensitive cause of housing
insecurity—on overdose risks are understudied. Eviction is a complex legal process composed of a series of
stages, each of which may impact overdose risk and thus offers opportunity for public health intervention. The
objective of this proposal is to pursue a thorough examination of the relationship between residential eviction
proceedings (i.e., filing, hearing, and enforcement) and overdose at the address level in Rhode Island, to better
inform eviction prevention policies that complement ongoing harm reduction and overdose prevention efforts.
The proposed research will leverage the wealth of centralized, high-resolution data available in Rhode
Island—and our team’s established relationship with the state health department—to construct a longitudinal
dataset with data linked from several administrative sources. We will first characterize the prevalence and time
course of eviction proceedings relative to non-fatal or fatal overdose events by conducting sequence and
cluster analyses to operationalize variation in the order, duration, and timing of eviction proceedings before and
after a given overdose event (AIM 1). We will then estimate the address-level causal effect of residential
eviction proceedings on risk of non-fatal and fatal overdose, both overall and by race and ethnicity of overdose
decedents, using a sequential target trial approach (AIM 2). The proposed research will be among the first of
its kind to link eviction records with address-level health data to characterize heterogeneity in the duration and
timing of eviction proceedings, to examine a causal link between eviction and overdose, and to explore
differential impacts of eviction on overdose death by race and ethnicity. Because eviction is an intervenable
mechanism of housing vulnerability that may be associated with overdose risk, findings from this work may
elucidate novel avenues for addressing the intersecting housing and overdose crises in tandem. The proposed
research will be completed by the principal investigator with support and mentorship from collaborators with
substantial expertise in advanced quantitative methods for life course epidemiology and causal inference. The
training activities detailed in this application, focused on advancing skills in epidemiologic study design and
longitudinal data analysis and developing a deep contextual knowledge of the social and legal implications of
eviction proceedings, will prepare the principal investigator for a career as an independent social
epidemiologist and academic researcher.

Public health relevance
PROJECT NARRATIVE Although housing insecurity is a well-documented risk factor for overdose, the particular effects of residential eviction—a structural and policy-sensitive cause of housing insecurity—on overdose risk remain understudied. The proposed research aims to characterize the prevalence and time course of residential eviction proceedings (i.e., filing, hearing, and enforcement) relative to non-fatal and fatal overdose events, and to estimate the address-level effects of residential eviction proceedings on overdose risk, both overall and by race and ethnicity. Findings from this work may inform policy solutions to address the intersecting housing and overdose crises in tandem.